Operation Whitecoat Tularemia Projects Study Records Conversion to Electronic Database

This IAA will support the translation of data from experiments using aerosolized Francisella tularensis, conducted on healthy human volunteers (Operation Whitecoat) by the United States Army, into a dedicated database that will be used to seek FDA qualification of an inhalational tularemia animal model.